In Vitro to In Vivo Extrapolation of Toxicant Effects on Ovarian Function

PROJECT SUMMARY
Approximately 7.5 million American women are unable to become pregnant or carry a baby to term (impaired
fecundity). The ovary is considered a critical target organ in infertility cases based on the large number of
women seeking infertility treatment who are unable to release a viable egg from their ovaries. Folliculogenesis
is the process through which ovarian follicles, the functional units of the ovary, develop into a form capable of
sustaining hormone production and ovulating a healthy egg for fertilization. Any environmental exposure that
causes damage to the ovarian follicle has the potential to impair fecundity in women. Most of what is known
about toxicity to ovarian follicles has been uncovered in laboratory rodents, but there is little available data on
toxicant exposure and related mechanistic toxicology studies in the nonhuman primate, the closest laboratory
animal model to humans. There is, therefore, a critical need to develop alternative approaches and tools that
synergize the accessibility and versatility of laboratory rodents with the physiological relevance of the
nonhuman primate to deliver high quality ovarian follicle toxicity data. To meet this need, this proposal will
support the formation of a virtual research consortium with expertise in mouse and nonhuman primate ovarian
biology, toxicology and computational modeling. The proposed consortium will generate lab-based data on the
physiological and toxicant-induced behavior of ovarian follicles in both species, using phthalate as a model
toxicant, to create computational models capable of effectively predicting ovarian follicle responses to chemical
insults in nonhuman primates. The experimental measures captured in the in vitro and in vivo model will be
specifically chosen to align with the needs of the modelers. To achieve this goal, the proposed consortium will
complete three specific aims. Specifically, the ovarian biology/toxicology team will quantify the physiological
and toxicant-induced behavior of computationally useful markers of in vivo and in vitro folliculogenesis in mice
(Aim 1) and nonhuman primates (Aim 2), while the computational modeling team will construct in silico models
that match the physiological behavior of folliculogenesis in each species and predict follicular responses to
phthalate insults in both species. Our virtual consortium includes researchers from five institutions and will
create a transdisciplinary group that includes both experimental and computational expertise. The tight
coupling of these two domains will provide the needed communication pathways to develop translational
models for IVIVE as well as cross-species extrapolations in reproductive toxicology.

Public health relevance
PROJECT NARRATIVE This proposal supports the creation of a virtual consortium that will use translational and transdisciplinary disciplinary approaches to provide the research community with an innovative computationally-based method to predict adverse effects of phthalates on ovarian function in women. This work will benefit human reproductive health by enhancing the screening of chemicals that could harm ovarian function in women. The transdisciplinary and translational environment created by this consortium will also provide unique cross- disciplinary training opportunities to trainees in the five institutions involved.